Child & Adolescent Mental Health Research

Abstract/Project Summary:
This application is a competitive renewal of 5T32 MH18951-32, a clinical/translational research training program
in child mental health (MH). Support is requested annually for 6 post-doctoral trainees (child psychiatrists and
doctorates in other disciplines) and 4 medical students for summer research electives. This 2-3 year postdoctoral
training program builds on previous success recruiting and training a diverse group of scientists who formulate
impactful research to improve child MH. The program targets current priorities in child MH research: improving
understanding of pathogenesis, course and treatment of child MH disorders; enhancing health equity; utilizing
technological advances; and community-partnered research. An accomplished multi-disciplinary Training
Faculty provides mentorship. Each trainee selects an academically successful mentor and 2 co-mentors who
together develop a career development plan with targeted goals for skill acquisition, presentations, publications,
pilot data, and grant proposal preparation. The mentors, trainee, Program Director and selected Training
Executive Committee (TEC) members review the plan every 6 months to ensure progress. An individually tailored
course of didactic study is developed for each trainee to ensure acquisition of knowledge in Core Content (e.g.,
research design, statistics). Trainees also participate in “Career and Research Development” seminars on grant
writing, project management, and training on responsible conduct of research. Monthly T32 seminars facilitated
by junior faculty further foster community among trainees and a forum for open dialogue around professional
development topics. Since the last renewal, we have further strengthened program leadership by expanding the
TEC; enhanced depth and breadth among our Training Faculty; offer monthly journal clubs led by Training
Faculty in Core Content Areas; and added an expert External Advisory Board. We now offer coursework in 3
Cross-Cutting Areas critical to the conduct of impactful clinical science in child MH: Health Equity, Technological
Advances, and Community-Based Research. There is high institutional commitment to this T32, with
Departmental salary and benefit supplementation, formal grant review processes for trainees, and extensive
CTSI resources to support project development and management. Of 27 T32 postdoctoral trainees since 2013,
70% attained faculty appointments and 70% received external funding (including 10 K-awards); 33% identify as
under-represented minorities. In the summer research program aiming to stimulate interest in child psychiatry
research, medical students work on a research project with a Training Faculty mentor. Of 40 predoctoral trainees
since 2013 (18% under-represented minorities), 78% entered a child-related residency and 88% published at
least one peer-reviewed paper.

Public health relevance
Project Narrative Research innovations in the field of child mental health conducted by specially trained clinician- scientists are desperately needed to adequately respond to the unprecedented youth mental health crisis in the United States. This T32 training program will build upon previous success in recruiting, engaging, and mentoring a diverse group of scientists who can advance the field in order to reduce the burden of child mental disorders. The program is designed to target current priorities in child mental health research, including: improving our understanding of pathogenesis, course and treatment of child mental health disorders; enhancing health equity; utilizing technological advances to enhance knowledge and care; and partnering with communities in the conduct of research.